Audiovisual processing in children with developmental language disorder

Project Summary – Audiovisual processing in developmental language disorder
Emerging developmental studies show that visual speech cues facilitate the acquisition of
important building blocks of language, such as phonemes and words, and shape the development of both
speech production and speech perception. Because visual speech cues influence multiple aspects of
typical language acquisition, and speech perception more generally, we ask whether impairment in the
processing of visual articulatory movements and/or difficulty in integrating such movements with
concurrent auditory speech may underlie some of the deficits observed in children with developmental
language disorder (DLD).
DLD is characterized by difficulties in acquiring language in the absence of an easily identifiable
cause, such as hearing impairment, frank neurological disorders, or low non-verbal intelligence. It affects
approximately 7% of preschool children in the US and is typically a life-long condition. Earlier studies
suggest that at least some aspects of audiovisual processing are impaired in DLD, but the causes remain
unknown.
In this project, we propose to examine in children with DLD and their typically developing (TD)
peers a set of mechanisms that are essential for normal audiovisual processing. These mechanisms include
the following: (1) sensitivity to temporal relationships between events in auditory and visual modalities;
(2) sensory encoding of speech-relevant visual features, namely shape and motion; (3) allocation of
attention to features of complex visual objects; and (4) knowledge of auditory/articulatory
correspondences for speech sounds. Examining these mechanisms in the same groups of children with
DLD and TD will provide information about both the hetero/homogeneity of audiovisual impairments in
DLD and the effects of impairment in just one vs. several mechanisms on audiovisual language use. We
combine behavioral measures with ERP and EEG data analyses in order to map the nature of neural
processes engaged by each mechanism.
Understanding the causes of audiovisual processing difficulties in DLD has significant clinical
implications. Audiovisual integration normally facilitates some of the linguistic skills that are impaired in
DLD, such as phonological and lexical processing and speech-in-noise perception. Hence, identifying the
mechanisms that prevent children with DLD from using visual speech cues as well as their TD peers do
and rehabilitating them could potentially lead to improvements in these linguistic skills. Additionally,
comparing the neural processes underlying audiovisual integration in children with typical and atypical
language ability provides a unique window into the development of the neural networks connecting
auditory and visual modalities and their impact on normal and disordered language function.

Public health relevance
Public Health Relevance Statement Developmental language disorder (DLD) affects at least as many children as autism and stuttering combined and has a life-long impact on individuals' well-being. Language acquisition is a multisensory process, in which seeing a talker helps children learn speech sounds and words of their language. Our earlier studies showed that the ability to combine information from audition and vision is impaired in children with DLD. The goal of this research is to identify specific neural mechanisms responsible for this impairment and help determine whether these DLD children's language acquisition and speech perception difficulties may be alleviated by therapy techniques that focus on enhancing audiovisual processing skills.